Retinal amino acid transport in health and disease

Lysosomes play a critical role in cellular metabolism, acting not only as catabolic hubs but also as the site
of nutrient sensing and metabolic signaling. Lysosomal dysfunction has been implicated in the blinding
disease retinitis pigmentosa. Mutation and deletion of lysosomal arginine transporters, including solute
carrier family 7 member 14 (SLC7A14), have been reported as causative genes for autosomal recessive
retinitis pigmentosa. However, it is currently not known how dysregulation of lysosomal arginine
metabolism causes vision loss. Our long-term objective is to determine how SLC7A14 mutations cause
blindness and the role for SLC7 A 14 in vision. The objective of this application is to determine the function
of SLC7A14 in endosomes/lysosomes and how mutation of SLC7A14 causes retinitis pigmentosa. The
significance of these studies includes resolving current fundamental questions on cellular
compartmentalization of metabolism as well as development of strategies for therapeutic approaches
targeting dysregulated metabolism in diseases. Our central hypothesis is that SLC7 A 14-dependent
lysosomal storage of cationic amino acids is essential for photoreceptor health. We will test this hypothesis
by determining and validating the cell type responsible for SLC7A14-mediated retinitis pigmentosa (Aim 1)
and by investigating the function and regulation of cationic amino acid transport by SLC7A14 (Aim 2). In
Aim 1, we will use mouse models to determine the cell type responsible for the pathogenesis of SLC7 A 14-
dependent vision loss, which is currently not known but is critical to understand disease pathology and
progression. We will test our hypothesis that loss of expression of SLC7 A 14 in horizontal and/or bipolar
cells causes retinitis pigmentosa. In Aim 2, we will use elucidate SLC7A14 transport kinetics and regulation
using cell lines and recombinant protein. We hypothesize that SLC7A14 aids in lysosomal storage of amino
acids to buffer cellular levels of cationic amino acids in times of amino acid scarcity. The outcomes of
studies will provide mechanistic insight into SLC7A14 function, which is essential to understanding the
function of SLC7A14 in the cell and how its dysregulation contributes to vision loss.